Macrophage driven, profibrotic adrenergic nerve remodeling in SSc-ILD

Scleroderma is a difficult to treat and poorly understood autoimmune condition characterized by dermal and
visceral fibrosis, sympathetic overactivity in the form of Raynaud’s phenomenon, and the accumulation of scar-
promoting innate immune cells such as macrophages. Despite the well accepted clinical relationship between
these entities, a mechanistic link has been neither proposed nor shown. Because we have a longstanding
interest in the role of neuronal guidance proteins (NGPs) such as Netrin-1 in SSc-ILD, we decided to study
whether Netrin-1 could connect these processes. Netrin-1 is a secreted, laminin-like protein that through
attractive and repulsive interactions with dependence receptors regulates critical events in injury, inflammation,
remodeling, and repair. In the developing CNS, NTN-1 guides the migration of axons, and in the periphery NTN-
1 guides both postnatal adrenergic innervation and sensory nerve regeneration via interactions with its attractive
receptor deleted in colorectal carcinoma (DCC). However, despite growing interest in nerve associated
mechanisms of injury and repair in peripheral organs, essentially nothing is known about how NTN-1 interacts
with adrenergic innervation in the fibrotic lung and, while nerve-derived signals are increasingly recognized as
regulators of macrophage function, the process by which macrophages might reciprocally maintain and remodel
adrenergic nerves in the healthy and diseased lung is obscure. Given SSc’s known association with sympathetic
dysfunction, better understanding of how adrenergic nerves are remodeled and maintained in SSc-ILD could
allow fundamental insights into the neuroscience of fibrosis. In this application we use mouse modeling and
SSc-ILD tissues to demonstrate aberrant adrenergic innervation, augmented Noradrenaline (NA), and NA-
responsive fibroblasts in the fibrotic lung. These factors interact to drive fibrosis, which can be inhibited via
chemical sympathectomy, pharmacologic inhibition of alpha1 adrenergic receptors, or specific deletion of NTN-
1 from macrophages. These findings support the hypothesis that macrophage derived signals such as Netrin-1
foster profibrotic adrenergic nerve remodeling in the lung and will be explored in three aims. This application
unites world class investigators in lung biology, scleroderma, innate immunity, adrenergic innervation, Netrin-1,
and neuroscience to conduct an integrated project using two animal models, cell specific knockout mice, shielded
bone marrow chimeras, pharmacologic receptor activation and inhibition, ex vivo study of human cells and
tissues, precision cut lung slices, single cell sequencing approaches, and microCT. Aim 1 will determine the
mechanism through which adrenergic nerve derived NA drives pulmonary fibrosis. Aim 2 will determine the
mechanism(s) through which Netrin-1+ macrophages regulates pulmonary fibrosis. Aim 3 will define how
macrophage derived Netrin-1 controls post-injury adrenergic nerve remodeling. These studies have the potential
to produce paradigm shifting results that will change the way we view fibrosis and potentially develop new
treatments for SSc-ILD.

Public health relevance
PROJECT NARRATIVE It is not known whether the heightened adrenergic activation seen in Scleroderma contributes to the interstitial lung disease (SSc-ILD) that complicates this disease nor whether this process is linked to innate immune cells such as macrophages. We have recently found evidence of macrophage driven, profibrotic adrenergic nerve remodeling in mouse models of SSc-ILD and in samples from patients with this condition. Our application will explore the mechanistic and therapeutic ramifications of this discovery with the hope of gaining new insights into this difficult to treat disease.